Role of lipoxygenase-derived lipid mediators in the hematopoietic niche

PROJECT SUMMARY
Hematopoietic stem and progenitor cells (HSPCs) closely interact with the niche microenvironment, allowing a
dynamic regulation on proliferation, differentiation and self-renewal. Various niche cells have been identified, yet
the secreted signaling factors in the hematopoietic niche are less well-defined, limiting the application of HSPC
for ex vivo expansion and enhanced engraftment protocol for blood disease treatment. To identify novel niche
factors that stimulate HSPC production, I performed an in vivo small molecule chemical screen and identified an
antagonist of cysteinyl leukotriene receptor 1 (CysLTR1) that stimulates HSPC divisions that specifically occurs
within a ‘pocket-like’ structure that is formed by a group of endothelial cells (ECs) in the niche. The HSPC is
known to physically interact with these ‘pocket’ forming ECs and the event is termed ‘endothelial cuddling’. A
HSPC division is often observed after endothelial cuddling, yet the mechanism is unknown. I performed single
cell RNA-sequencing (scRNA-seq) analysis of zebrafish hematopoietic tissues and identified that CysLTR1 is
specifically expressed in a subset of ECs with high expression of niche EC genes. I generated a stable
cysltr1:mCherry reporter fish and found that cysltr1:mCherry+ ECs preferentially interact with HSPCs. I
generated a stable cysltr1 knockout fish and it phenocopied the antagonist perturbations. Cysteinyl leukotrienes
(CysLTs) are lipoxygenase (LOX)-derived lipid mediators. I further performed lipidomic analysis of zebrafish
hematopoietic tissues and identified a series of LOX-derived lipid mediators. Interestingly, I performed scRNA-
seq analysis and found that corresponding receptors of these lipid mediators were expressed in distinct cell
types such as macrophages, neutrophils or stromal cells, indicating unique mechanisms. LOX-derived lipid
mediators play key roles in inflammation. However, the role of LOX-derived lipid mediators in the hematopoietic
niche remains unexplored. Given my preliminary data, I hypothesize that LOX-derived lipid mediators
remodel hematopoietic niches by altering cellular interactions and secreted cytokines to regulate
hematopoiesis. Under the supervision of Dr. Leonard Zon, the field-leading expert in hematopoiesis and
zebrafish genetics, I will test my hypothesis using high resolution live cell imaging, chemical biology and
CRISPR/Cas9 mutagenesis. I have put together a panel of scientific advisory committees who are field-leading
experts in vascular biology, niche cell biology, and lipid mediator biology. Together with Dr. Zon, I will receive
constant feedback on my research and career development. This K99/R00 award will enable me to gain trainings
and acquire skills in scientific training and career development that prepare me to start my laboratory. My
overarching goal is to investigate molecular mechanisms of niche-mediated regulations in hematopoiesis in my
own laboratory. I aim to contribute my research discoveries to develop enhanced HSPC ex vivo expansion
protocol through recapitulating the functional niche signaling and to improve the efficiency and safety of
therapeutics through targeting/priming the hematopoietic niche.

Public health relevance
PROJECT NARRATIVE I aim to characterize the role of lipoxygenase-derived lipid mediators in the hematopoietic niche. I will utilize genetics, chemical biology, and confocal live cell imaging to determine and visualize the dynamic cellular and niche alternations mediated by lipoxygenase-derived lipid mediators. These studies will provide novel insights into our understanding of how lipoxygenase-derived lipid mediators in the niche modulate hematopoiesis and will lead to novel therapies targeting the hematopoietic stem cell niche.